RETROVIRAL ONC GENES AND CELLULAR PROTO ONC GENES

It is proposed to analyze the genetic structure and, in particular, the transforming onc genes and proteins of avian and murine retroviruses and of their cellular prototypes, termed proto-onc genes. Viral onc genes consist of specific elements derived from cellular proto-onc genes as well as from retroviral genes. For this reason, it is now widely believed that proto-onc genes can function as cellular cancer genes upon transcriptional or mutational activation. This project will analyze common and specific properties of corresponding onc genes and proto-onc genes, in order to determine whether and under which conditions proto-onc genes may function as cancer genes. The studies will first involve structural analyses of onc genes and proto-onc genes. Subsequently, the function of structurally defined onc- and proto-onc-gene domains will be analyzed in viral vectors by deletion analyses and by in vitro recombination analyses between the onc genes of cloned retroviruses with corresponding proto-onc genes.